Biostatistics & Informatics Shared Resource

BIOSTATISTICS AND INFORMATICS SHARED RESOURCE (BISR): ABSTRACT
The Biostatistics and Informatics Shared Resource (BISR) plays an essential role in the research activities of
The University of Kansas Cancer Center (KUCC) by supporting the data science needs of KUCC investigators.
The BISR is co-led by Byron Gajewski (CPC), PhD, and Devin Koestler (CB), PhD, both accomplished
biostatisticians with a long-standing commitment to cross-disciplinary collaborations. The BISR includes 19
faculty members with specialized cancer biostatistics research expertise, 13 technical support staff and
postdoctoral fellows, and three administrative staff members who provide additional technical and
administrative expertise, adding efficiency to the resource. The BISR assists KUCC investigators by providing
guidance and direction in study design, statistical oversight and analyses, clinical research informatics and
data management, electronic data collection, bioinformatics, complex data set (statistical ‘omics) analysis, and
investigator-initiated clinical trials.
The BISR consists of faculty and staff whose diverse expertise and skill sets span the areas of biostatistics,
bioinformatics, and informatics. The considerable overlap between these three areas allows researchers to
work with a single shared resource for their data collection, analytics, and statistical analysis needs. The
synergy between the areas that encompass “data science” enables the BISR to support a wide range of quality
services in a timely and cost-effective manner. To support the research activities of KUCC members, the
specific aims of this resource are to: 1) provide study design and statistical support and expertise; 2) provide
bioinformatics and statistical genetics support and expertise; 3) provide informatics expertise for data collection
and management, as well as develop and support ongoing research enabling technologies, platforms, and
tools; and 4) educate students, fellows and faculty members of KUCC on data science, reproducible research
ideas, and methods used in cancer research. From 2016-2020, the BISR supported 69, 60, 85, 80, and 78
KUCC members respectively. In 2020, the breakdown was 18, 33, and 27 members from Cancer Biology,
Cancer Prevention and Control, and Drug Discovery, Delivery and Experimental Therapeutics, respectively, on
89 grant applications (submissions and resubmissions) and 161 projects (ongoing grants, IITs, and other
projects). In addition, the BISR supported 31 non-member cancer researchers in 2020. For all cancer-related
projects, the BISR supported 340 grant applications plus projects in 2020. In 2021, CCSG funding accounts for
~10% of the BISR budget, with an annual direct support return on investment of approximately $0.6M dollars in
external funding to support BISR faculty and staff (31% of BISR support).